Tissue Engineering Resource Center

SUMMARY
The Administration Core of the Center will provide the exchange of information, guide strategic planning
and coordination within the Center, make decisions about the collaborative projects (CPs) and service
projects (SPs), monitor accomplishment of the aims for each component of the Center, monitor budget
allocations and the development and utilization of resources, and oversee the dissemination and
outreach. The Administrative Board (PD/PI, PIs of the TRD1 and TRD3, Research Coordinator and
Administrative Coordinator) will oversee the overall operation of the Center. Three specific aims will be
pursued. Aim 1: Management of the Center's activities. The Administrative Core will provide the
financial support, logistics and oversight of the progress for each individual TRD, CP, SP, and foster
synergistic interactions between the Center's components towards accomplishing the Center's mission.
Aim 2: Support of Communications, Dissemination and Outreach. The Administrative Core will
support the communications within the Center, dissemination of the Center's results and capabilities to
the academic community, clinicians and commercial sector, and outreach to the public community. Aim
3: Management of Technology Translation and Commercialization. The Administrative Core will
oversee the Collaborative Projects and Service Projects, and the translation and commercialization of
the Center's most promising products and technologies.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The mission of the proposed Tissue Engineering Resource Center is to advance the field of tissue engineering and its therapeutic applications in regenerative medicine by developing next-generation technologies. The Administrative Core will coordinate the many functions of the Center, along with the oversight of the progress, budget allocations and compliance with the research ethics.